SCH: An Augmented Reality Neurorehabilitation System for Monitoring and Management of Motor Symptoms of Parkinson's Disease

PROJECT SUMMARY (See instructions):
This project proposes augmented reality eyeglasses that can be worn throughout the day by a person with
Parkinson's disease (PD) undergoing neurorehabilitation. The system enables (1) monitoring of and
feedback to the patient during clinic visits, with provider-supervised physical therapy (PT) exercises, (2)
display of immersive guidance and feedback to the patient during PT exercises at home that reference
exercises supervised in the clinic, and (3) monitoring, analysis, and summarization of the patient’s activities
of daily life (ADLs) between clinic visits, through cameras integrated into the eyeglasses and inertial
sensors in shoes and wristbands. To develop such a system, we will advance the state-of-the-art in four
research thrusts - egocentric tracking and reconstruction, egocentric visual perception, personalized
reasoning models, and immersive analytics. In the first thrust, we will investigate the use of deep neural
network architectures for highly accurate, clinically useful egocentric tracking and 3D reconstruction,
enabling us to meaningfully record, playback, and evaluate rehabilitation activities. In the second thrust, we
will develop a rich semantic understanding of contextualized activities using multimodal deep learning
models that take into account short-term and long-term data from wearable inertial sensors and multiple
egocentric cameras. In the third thrust, we will develop novel reasoning systems based on graphical
models that leverage techniques such as partially observable Markov decision processes (POMDPs) to
track and predict aspects of user performance during rehabilitation activities. In the fourth thrust, we will
design an immersive analytics front-end interface that will integrate with our reasoning systems to provide
customized user feedback and clinician summaries, enabling improved patient care. Developments across
each of these thrusts will be integrated into an eyeglasses-based augmented reality system that will be
iteratively evaluated and refined, first with able-bodied participants in a controlled lab setting, next with
Parkinson’s patients in a clinical setting, then with able-bodied participants in home settings, and finally with
Parkinson’s patients in their home environment.

Public health relevance
RELEVANCE (See instructions): Our proposed system has the potential to dramatically improve clinician decision-making and slow the functional decline caused by Parkinson’s disease. We envision a future where patients may be remotely guided through treatment and monitored such that clinicians can rapidly and effectively provide assistance outside of clinical settings. Our research contributions may also support the management and monitoring of a broad category of other chronic diseases.